2025 Elastin, Elastic Fibers and Microfibrils Gordon Research Conference and Gordon Research Seminar

Project Summary/Abstract
Elastin, elastic fibers, and associated microfibrils are connective tissue molecules that provide recoil to tissues
that stretch. They are critical to the function of numerous organs, with highest concentrations in arteries,
ligaments, lungs, and skin but are also key to the function of female genitourinary organs, tendons, eyes, and
bone. Elastin’s deposition is tightly developmentally controlled, but once in the extracellular space, it has a
prolonged half-life. Currently, knowledge is lacking as to how to reactivate elastin deposition outside of early
developmental periods, leading to limited ability of the body to repair and regenerate elastic tissues.
Consequently, elastin’s eventual turnover is associated with many pathologic features of aging while
accelerated turnover is seen in a variety of common health conditions ranging from aneurysm and emphysema
to tendinopathy and pelvic organ prolapse.
The Elastin, Elastic Fibers and Microfibrils Gordon Research Conference (GRC) will provide in-depth
discussion of elastic tissue biology with an emphasis on sessions that delve into mechanisms governing the
timing and extent of elastic fiber protein production and their contribution to disease. Sessions cover a broad
range of topics including molecular properties of elastin relevant to biomaterials, mechanisms of transcriptional
and translational control, inflammation and maintenance of elastic fibers, novel imaging and big data
techniques to quantify elastin and assess its impact, and sex and tissue specific control of elastin deposition.
Evening sessions are focused on disease mechanisms relevant to the biology discussed in the morning and
cover a comprehensive set of key organ systems: heart, lung, musculoskeletal, integumentary and
ophthalmologic. Featured sessions on women’s health topics as they relate to the regenerative potential of
elastic fibers and one on therapeutics are also included.
The aims of the conference are the following: 1) Generate novel research questions by integrating data from
elastin-related and broader scientific fields; 2) Drive medical research by bringing to light new data with high
translational potential in the areas of diagnosis, management, and treatment of acquired and genetic disorders
involving elastic fibers and microfibrils; 3) Promote the early integration of young scientists from a variety of
backgrounds into the elastin community; 4) Address issues related to rigor and reproducibility of data in the
elastin biology field; 5) Provide an inclusive environment for a diverse set of scientists with broad expertise
relevant to elastin to exchange ideas, accelerate research, and catalyze collaborations.
The 2025 Elastin, Elastic Fibers & Microfibrils GRC will focus on recent novel, unpublished data and will
stimulate collaborations, and novel hypotheses by integrating participants from varying disciplines and
backgrounds. The accompanying Gordon Research Seminar will allow trainees to interact with established
investigators, present their data, and learn career development skills.

Public health relevance
Project Narrative Elastin is an abundant matrix protein in the lungs, skin, arteries, and ligaments, and it performs the unique and critical function of providing elasticity to these organs. The 2025 Elastin, Elastic Fibers & Microfibrils Gordon Research Conference and Gordon Research Seminar will assemble the world’s experts in the elastin field to learn and discuss recent developments in the field, establish collaboration to move the research forward, and mentor a diverse group of trainees for success in science. Key invitations to scientists currently outside the area will facilitate the introduction of new ideas to expand the reach and impact of the elastin field.